CONTINUITY SUMMER WORKSHOP

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This event is held on demand during the summer months, if some students cannot attend the NBCR summer institute due to schedule conflict..